Development of Novel Therapeutics for Asthma

Development of Novel Therapeutics for Asthma
BioTherapeutics Inc (BTI) is an emerging biotech company that synergistically combines the power of
advanced computational modeling with translational experimentation to accelerate the development of novel
precision medicine therapeutics for asthma, allergy and autoimmune diseases. An unmet clinical need for safer,
more effective drugs for asthma remains as current therapies have limited efficacy and adverse side effects.
Asthma is a chronic, widespread allergic disease with total expenses exceeding $80 billion annually in the U.S.
Current therapies for asthma are modestly effective with significant side effects. Specifically, type 2 asthma
patients can develop steroid dependency in neutrophilic asthma, while non-type 2 asthma has a lower
responsiveness to current treatments. Recent attempts to target this population have been unsuccessful, with
anti-TNF, anti-IL-17 receptor and chemokine inhibitors failing in clinical trials, while macrolides and methotrexate
have shown mild improvement but at high side effect risk. Thus, there is an unmet medical need for safer and
more efficacious asthma therapeutics. In the last years, regulatory T (Treg) cells have gained increased
recognition in the treatment of inflammatory and allergic diseases. Furthermore, metabolic dysregulation has
also been associated with the pathogenesis of this complex disorder. Immunometabolic manipulation of Treg
cells to restore their suppressive capacity has been postulated as a promising novel therapeutic approach for
asthma. Indeed, in asthma patients, Treg cells present deficient suppressive ability. Administration of Tregs in
animal models of allergic asthma can resolve the established chronic inflammation. Moreover, targeting of
glucose and oxidative metabolism have also resulted in decreased inflammation and airway
hyperresponsiveness. This SBIR Phase I application will develop a novel immunoregulatory and
immunometabolic therapeutic for the treatment of asthma. The Specific Aims are to:
Aim 1. Determine the safety profile and pharmacokinetics (PK) of the new immunoregulatory therapeutic
by evaluating oral bioavailability and distribution and conducting general toxicity studies in rats.
Aim 2. Characterize the therapeutic efficacy and route of administration of the new immunoregulatory
therapeutic using ovalbumin and house dust mite induced models of neutrophilic asthma. Efficacy studies will
be determined by airway resistance, lung histopathology, flow cytometry and cytokine expression.
Expected successful outcomes are: i) ≥ 50 % decrease in lung histological lesions and ≥40% decreased
infiltration of eosinophils and neutrophils in the lungs; ii) ≥ 50% suppression of airway resistance; iii) ≥ 50%
decreased infiltration of neutrophils in the lungs of treated mice; and iv) lung concentrations ≥ 25 ng/g and
NOAEL ≥ 1,000 mg/kg in rats.
Commercial Application: The impact of this new, oral, immunoregulatory asthma drug has the potential to
address the unmet needs of 27 million U.S. patients and disrupt an global market of $20 billion/yr by 2026.

Public health relevance
Public Health Relevance Asthma is a chronic, widespread allergic disease with total expenses exceeding $80 billion annually in the U.S. Current therapies for asthma are modestly successful but leave significant subpopulations of patients without adequate response. This SBIR Phase I application will develop a new oral immunoregulatory therapeutic targeting a novel mechanism of action that enhances Treg function for the treatment of asthma.